Nonsense-mediated mRNA decay and beyond

This MIRA application extends our decades-long research on nonsense-mediated mRNA decay (NMD) and
how NMD factors can function in other aspects of cellular metabolism. NMD is a fundamental biological
process by which mammalian cells eliminate mRNAs containing a nonsense codon deriving a genetic or
acquired frameshift or nonsense mutation. NMD also eliminates an estimated one-third of mRNAs that cells
produce by routine mistakes made during gene transcription and/or mRNA production. Over the years, we
have worked to elucidate the molecular mechanism of NMD. As one of many outcomes, we have established a
“rule” that clinicians and researchers use to predict which nonsense codons result in recessively inherited vs.
dominantly inherited disease. We have also demonstrated how cells regulate the efficiency of NMD as an
adaptive mechanism during changing environments, e.g. during development, differentiation or drug
treatments. This application pursues our serendipitous finding that NMD is hyperactivated in fragile X
syndrome (FXS), which is the most common single-gene cause of intellectual disability and autism, affecting
1/4000 boys and 1/6000-8000 girls. We aim to understand how the protein that is missing in FXS functions via
interactions with other proteins and mRNAs to protect these mRNAs from translation and decay. We also aim
to decipher the mechanism by which the RNA-binding protein Staufen prevents a runaway immune response.
On another front, our long-time interest in mechanistic connections that extend from pre-mRNA splicing in the
nucleus to mRNA translation and decay in the cytoplasm will be extended to gene transcription and nuclear
mRNA decay. We have long been fascinated by the structural dynamics and functions of the largely nuclear
cap-binding heterodimer CBP80−CBP20, which binds co-transcriptionally to the 5'-cap of nascent pre-mRNAs.
While our past interests have focused on the role of CBP80−CBP20 in the pioneer round(s) of cytoplasmic
translation, during which we have shown exon-junction complex-mediated NMD occurs, we are now in pursuit
of understanding roles of CBP80−CBP20 in the nucleus. As one example, we are studying the mechanism by
which a master transcriptional co-activator of genes whose products regulate critical cellular processes
engages with CBP80−CBP20 so as to promote the expression of an understudied category of RNA
polymerase III-transcribed genes. In related work, we are studying connections between CBP80−CBP20 and
the little-understood, and so-called, nuclear cap-binding protein (NCBP)3 to elucidate the significance of our
finding that NCBP3 regulates newly made mRNAs from genes encoding proteins that function in mitochondrial
biology. These connections will be examined in skeletal-muscle cells in vitro and ex vivo, the latter using mice,
which should lend insight into the etiology and pathogenesis of many human diseases that include sarcopenia,
neuromuscular disorders, and cardiomyopathies. While are interests are broad, they are connected by the goal
to understand molecular mechanisms in health and in disease, with a focus on RNA metabolism.

Public health relevance
Maquat-lab research focuses on RNA metabolism in human health and disease. The lab’s view is that understanding the molecular mechanisms of normal gene expression and what goes wrong with these mechanisms in disease are critical for the development of effective therapeutics. Disease states to be examined include fragile X syndrome, which is the most common single-gene cause of intellectual disability and autism, and a runaway innate immune response, which can lead to a cytokine storm in cases of bacterial or viral infections, including COVID-19.